Toward Personalized Therapeutics: Directed Remodeling of the Gut Microbiome to Treat Atherosclerosis

PROJECT SUMMARY/ABSTRACT
Gut microbiome is a dynamic and malleable microbial community vital to the maintenance of human and
animal health. However, under the influence of a calorically rich Western-type diet, a healthy gut microbiome can
transform into a dysfunctional state promoting the onset and progression of several non-communicable chronic
diseases, including atherosclerosis. A central unresolved question had been whether and how it might be
possible to remodel a dysfunctional gut microbiome within a living human or animal to treat or prevent disease
progression. We now show that this indeed can be achieved. Building on our recent discoveries and advances
highlighted here, the proposed multidisciplinary research program is aimed at developing novel chemical agents,
advanced screening methods, and predictive bioinformatic tools to help identify and validate the biological
mechanisms driven by an imbalanced gut microbiome that fuel chronic inflammation and progression of
atherosclerosis.
We provide Preliminary Results data to show, for the first time, that a dysfunctional gut microbiome induced
by a Western diet (WD) can be selectively remodeled in vitro and in vivo to prevent the development of
atherosclerosis. We disclose that self-assembling eight-residue cyclic D,L-a-peptides selected from a novel en
masse in vitro screening protocol can function as bacterial growth modulators and in a targeted manner remodel
a WD-induced dysfunctional gut microbiome in vivo to prevent development of atherosclerosis in LDLr-/- mice.
Directed remodeling of the gut microbiome following 10-week daily oral administration of two lead peptides to
mice caused diverse and beneficial biological effects in the host, including marked reductions in plasma total
cholesterol levels and atherosclerotic plaques, extensive reprogramming of the microbiota and host
transcriptomes, increased populations of intestinal Helios+ Treg immune cells, suppressed the production of a
number of pro-inflammatory cytokines (including IL-6, TNF-a, and IL-1b), improved gut barrier integrity, and
rebalanced levels of disease-relevant metabolites, such as short-chain fatty acids (SCFAs) and bile acids.
Building on these advances, the proposed studies seek to improve and exploit our in vitro method for
compound screening against gut microbial populations as a whole to identify molecules that can selectively
modulate the overall microbiome composition without significantly reducing species diversity/richness.
Complementary to the screening efforts are a host of mechanistic studies carried out in animal models of
atherosclerosis. Comparative analyses of the microbial metagenomics and host transcriptomics for treated vs.
control animals would provide data for developing improved compound scoring and categorization tools. Our
research program focuses on characterizing and manipulating the microbiome in its entirety, and this approach
could provide new tools and methods for exploring host/microbiome interactions, interrogating specific
mechanistic questions, and identifying novel pathways and therapeutic targets.

Public health relevance
PROJECT NARRATIVE Western diet along with sedentary lifestyle has been shown to transform the microbial community colonizing the human gut into a dysfunctional state promoting systemic inflammation and the onset and progression of several non-communicable chronic diseases. We have developed a novel approach for directed remodeling of a dysfunctional gut microbiome into a healthy state that reduces the development of atherosclerosis in mouse models of the disease. As a step toward the long-term goal of advancing a new generation of personalized cardiovascular disease interventions and therapeutics, we propose to build on our recent discoveries and develop novel methods to facilitate discoveries and a better understanding of the chemical biology of the gut microbiome.